Mechanisms of innate resistance to virus infections

Project Summary / Abstract
No changes from originally proposed project.

Public health relevance
Public Health Relevance Statement No changes from originally proposed project.